FILGRASTIM (FHUG CSF) AND HYDROXYUREA IN PATIENTS WITH SICKLE CELL DISEASE

This study will evaluate whether Filgrastim will ameliorate hydroxyurea associated myelosuppression and whether the two drugs will increase fetal hemoglobin levels in patients with sickle cell disease.